Training in Sleep, Circadian, and Respiratory Neurobiology

1 In its most recent research plan, the NHLBI’s National Center for Sleep Disorders Research identified the need
2 to foster a strong and diverse workforce as its central priority. The Harvard Medical School Division of Sleep
3 Medicine Program for Training in Sleep, Circadian and Respiratory Neurobiology, is based at the Brigham and
4 Women’s Hospital and conducted in partnership with the Morehouse School of Medicine. Over the past 24 years,
5 this program has evolved to rise to the new challenges in our field, including increasing diversity, equity and
6 inclusion of the workforce, such that 8 of our 19 currently-appointed trainees (42%) are from under-represented
7 race/ethnicity, disability, or disadvantaged backgrounds. This program provides targeted, structured, and
8 comprehensive research training to prepare outstanding individuals of diverse backgrounds for academic
9 positions in the broad fields of sleep, circadian and respiratory neurobiology. For each trainee, the training
10 program consists of core required courses and activities, elective courses and activities, and an intensive
11 research experience. Cross-disciplinary and translational research is a highlight of this program, and formal
12 mentoring and tracking components are integral features. Intensive research training experiences are available
13 across the breadth of sleep, circadian and respiratory neurobiology areas, including basic, translational, and
14 clinical research opportunities, with two program projects that span multiple laboratories and institutions. There
15 are 27 Full Preceptors that span 9 institutions, including 2 medical schools, with extensive experience and
16 demonstrated success at training pre-doctoral and post-doctoral fellows, well-funded research programs
17 (supported by $31 million of direct costs annually), and outstanding resources that trainees utilize for research.
18 In addition, we have 7 Associate Preceptors who are actively being trained to be our next generation of mentors.
19 Our training record over the past decade reveals the success of our efforts to train leaders in academic sleep
20 science. Of our pre- and post-doctoral trainees funded by this training grant over the last 15 years, 96% and 94%
21 of our pre-doctoral and post-doctoral trainees, respectively, are currently active in academic/research-intensive
22 careers, with 77% of our post-doctoral trainees currently employed in academic research careers. Of the 37
23 post-doctoral trainees who were supported by this training grant before 2014, 54% report being PI on a research
24 grant (54%), almost all of whom have a faculty rank of Assistant Professor or higher. These data demonstrate
25 the successful record of our participating faculty at training both pre- and post-doctoral trainees for research-
26 intensive careers. Funds are requested to support four pre-doctoral graduate students, three pre-doctoral short-
27 term summer minority medical students, and eight post-doctoral trainees. Based on our highly competitive
28 application process, we are confident these slots will be filled by outstanding future leaders. This program has
29 grown and been refined over the two decades since its inception and meets the nationally-recognized need to
30 increase the number of diverse, highly-qualified investigators in sleep and circadian science and medicine.

Public health relevance
Sleep and circadian rhythm disorders, which are highly prevalent and have a major impact on physical and behavioral health, safety, quality of life and longevity, disrupt the lives of an estimated 50-70 million Americans. At the core of the strategic goals laid out in the 2021 NIH Sleep Research Plan is the recognition of the critical need to foster a strong and diverse workforce required to accelerate fundamental scientific discoveries and translate these to clinical practice and population health to advance public health and safety, transform health care and advance well-being for our nation’s diverse population. Our NHLBI-supported Training Program in Sleep, Circadian and Respiratory Neurobiology directly addresses this need by training a diverse generation of investigators, many of whom are already successfully tackling critical questions in biomedical research aimed to understand the pathophysiology, prevention and treatment of sleep and circadian disorders.